Regulatory Pathways Compromised by PRMT5 Inhibition in Cancers with MTAP Loss

PROJECT SUMMARY
The arginine methyltransferase PRMT5 has been identified as a potential target in cancers with loss of the
metabolic enzyme MTAP, which occurs in ~15% of all malignancies including several (such as glioblastoma,
pancreatic ductal adenocarcinoma, and esophageal cancer) that are refractory to standard therapies. MTAP loss
partially impairs PRMT5 activity and sensitizes MTAP-deleted cancer cells to pharmacologic PRMT5 inhibition.
As a result, the development of PRMT5 pathway inhibitors has accelerated, including two PRMT5 inhibitors
recently reported to have clinical activity in patients with various MTAP-deleted solid tumor malignancies. While
PRMT5 is a well-established regulator of multiple cellular pathways including transcription, RNA processing, and
DNA repair, how it regulates these pathways and which processes are critical for maintaining cell viability is
unclear. To address this knowledge gap, a genome-scale CRISPR activation platform has been leveraged to
identify genes that modulate sensitivity to PRMT5 pathway inhibition in MTAP-deleted cancer cell models.
Among the top-scoring gene products that reduce sensitivity of MTAP-deleted cells to PRMT5 pathway inhibition
are previously unrecognized regulators of DNA damage response (DDR) and potential new PRMT5 substrates.
The overall objective of this proposal is to define key components of the PRMT5 axis that impair cell viability
upon PRMT5 inhibition and to define pathways that can restore viability. The central hypothesis is that the top-
scoring gene products that reduce sensitivity to PRMT5 pathway inhibition represent previously unrecognized
regulators of DDR, activate DDR pathways that protect cells from PRMT5 pathway inhibition, and may represent
core PRMT5 pathway components. This hypothesis will be tested by pursuing 2 specific aims: 1) Determine how
top-scoring proteins mediate responses to DNA damage and 2) Define mechanistic connections between top-
scoring proteins and the PRMT5 pathway. The project will examine the impact of these gene products on
generation of double-strand DNA breaks, R-loop formation, and homologous recombination (HR) pathways.
Proteomic, biochemical, and genetic approaches will be leveraged to gain mechanistic insights about how these
proteins intersect with the PRMT5 axis. The proposed work is significant because it will define genes and
pathways capable of restoring viability of MTAP-deleted cells exposed to PRMT5 pathway inhibition and will
inform a molecular and functional annotation of downstream effects of PRMT5 and compensatory pathways.
The approach is innovative and distinct from prior studies because it builds on functional genomic insights to
focus squarely on the therapeutically relevant functional roles of PRMT5. Successful completion of these aims
will identify processes dysregulated by PRMT5 inhibition that impair cell viability, delineate molecular mediators
of these processes, and provide fundamental insights about mechanisms of DDR regulation. The work may also
identify additional therapeutic targets in the PRMT5 axis.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health and the mission of the NIH because it will provide a molecular and functional annotation of downstream effectors and pathways regulated by PRMT5, an important therapeutic target in cancer. The work is expected to reveal fundamental insights about regulation of key biological processes including DNA damage response and RNA metabolism, pathways compromised with PRMT5 inhibition in MTAP- deleted cancers. As MTAP loss occurs in approximately 15% of all cancers, findings from the proposed studies will be relevant to multiple malignancies refractory to standard treatments and may inform therapeutic strategies for MTAP-deleted cancers.